Clinical validation of Duoseq, a Swiss army knife genomic approach to diagnosis of blood cancers

ABSTRACT
DNAseq and RNAseq are powerful and complementary next generation sequencing (NGS) assays for
characterizing cancers. Together, these assays can recapitulate nearly all the diagnostic workup of many tumors.
However, significant barriers prevent its actual application in the routine diagnosis of cancers. First, these assays
are complex and usually separate, with different workflows and timelines for sample preparation. Second, the
bioinformatics analyses needed to interpret the data are complex and difficult to implement. Third, the turnaround
time for NGS assays and analyses typically stretches over a week, making it difficult to incorporate into diagnostic
workups.
To overcome these limitations, we have developed Duoseq, a novel clinical approach for dual DNA and RNA
sequencing from a single workflow. Duoseq also includes bioinformatics software that connects directly to the
NGS sequencer to provide DNA mutations, copy number and translocation status, as well as expression data
for markers recommended by standard clinical guidelines. We have initially developed Duoseq as a solution that
uses DNA and RNA sequencing for the diagnosis of blood cancers.
The average blood cancer biopsy is subjected to a battery of time-consuming diagnostic tests that require
subjective interpretation by pathologists. Duoseq is currently available for clinical adoption as an assay that
reports single nucleotide variants (SNVs), small insertions/deletions (indels) and translocation and fusion status.
However, Duoseq has the potential to deliver many other essential molecular diagnostic readouts including (i)
copy number alterations, (ii) immunoglobulin heavy chain variable region mutation status, (iii) viral infection
status and (iv) diffuse large B cell lymphoma subtypes. Adding these applications would render Duoseq a
comprehensive profiling assay that could replace a vast suite of different assays currently used in the clinic to
determine these features, thus saving costs, time and precious biopsy material.
In this Phase I proposal, we will perform the analytical and clinical validation of these extended Duoseq
applications. These studies are necessary for an FDA application and will significantly advance Duoseq toward
clinical implementation in blood cancer diagnostics.

Public health relevance
PROJECT NARRATIVE The average blood cancer biopsy is subjected to a battery of time-consuming and expensive diagnostic tests that require subjective interpretation by pathologists. We have developed Duoseq as a novel genomic approach for sequencing DNA and RNA together with included bioinformatics to comprehensively profile blood cancers nearly ten times faster and cheaper than current standard methods. The success of this proposal will facilitate widespread adoption of Duoseq as a comprehensive genomic profiling assay for blood cancers.